Population Genomics of Host-Microbiome Interactions

Population Genomics of Host-Microbiome Interactions
The composition of the microbial communities that colonize the human body varies widely across
individuals and populations, and has been associated with numerous host traits and diseases. Although the
microbiome is influenced by environmental factors, a strong host genetic factor is also expected to control the
interaction between humans and the microbiome. Understanding the relative role of genetic and environmental
factors in host-microbiome interactions is a central goal in human disease research. However, we know very
little about the genomic factors that control the interaction between humans and the microbiome and their
effect on complex human disease. It is often difficult to disentangle genetic from environmental effects on the
microbiome, and studies only consider the microbiome in a single time point, which could be problematic given
the microbiome can vary dramatically day-to-day and throughout an individual's life. Moreover, as most
microbiome studies identify correlations, we do not know how inter-individual and inter-population variation in
microbiome composition affects host physiology.
In this proposal, I outline a long-term research strategy to address these critical gaps in knowledge.
Research in my lab is based on the hypothesis that the microbiome can be considered a quantitative trait, and
thus we can directly map host genomic factors controlling the variation in the microbiome, as well as identify
individual host genes and pathways that are regulated by the microbiome. Here, I outline my lab's research
program for the next five years, designed to answer fundamental questions about the genetic basis of host-
microbiome interactions via three broad, complementary Project Areas, aiming to: (1) collect and integrate host
and microbiome genomic data to achieve a systems-level understanding of host-microbiome molecular
interactions in the colon; (2) characterize the heritability of life-long longitudinal microbiome dynamics in a
primate model system; and (3) use novel in vitro and ex vivo systems to understand the effect of inter-
population variation in the microbiome on host gene regulation and describe the underlying regulatory
mechanism.
The proposed research program will provide a systems-level view of the molecular interactions between
host genes and microbial taxa, genes, and pathways in the gut; a characterization of how microbiome
dynamics and taxa are controlled by host genetic variation; and a description of the mechanism with which the
microbes regulate host genes. These results would transform our understanding of the interplay between
human genomics and the microbiome, explain how this interaction affects disease, and would enable
development of microbiome-based therapeutics and diagnostics that improve human health.

Public health relevance
Project Narrative Although the gut microbiome and human genetic variation are both associated with human disease, we do not know what are their relative contributions and how these two factors interact in affecting susceptibility to complex disease. Here, we propose to use a combination of genomic, computational, and experimental techniques to identify host genes and pathways that control microbiome composition, as well as individual microbiome taxa, genes, and functions that modulate gene expression in the human host. Results from this project will generate unprecedented insight on the interaction between human genetics and the microbiota in disease, and have a strong potential to facilitate novel microbiome-based diagnostics and therapeutics.